Core--Career development program

The goal of this Career Developmental Program (CDP) is to support the multi-disciplinary training of junior investigators past their post-doctoral career who have an outstanding academic track record and wish to engage in molecular imaging research to ultimately establish an independent research program. Funds are requested to support two trainees per year. The CDP emphasizes the cross-training of basic (PhD) and/or clinical [MD or MD/PhD] and/or clinical (MD or MD/PhD) scientists in the principles of molecular techniques to answer basic science questions through in vivo imaging. Overall, we believe that the development, validation, and application of novel imaging techniques (e.g. receptor mapping, imaging of should further enhance tour understanding of disease mechanisms and go hand in hand with the development of molecular medicine. The program consists of didactic lectures, laboratory exercises, individual research projects and a mentorship program. Trainees who successfully complete the program are excellent candidates for leadership positions in Molecular Imaging Programs. The primary consists of 14 senior scientists with extensive experience in training. The faculty has over 35 extramural research grants including over 15 NCI grants that directly addresses issues of cancer diagnosis and therapy using novel imaging approaches. The faculty has supervised over 300 pre and postdoctoral fellows and over junior investigators in various aspects of basic and clinical research. We have also developed successful that, with our current faculty, facilities, scape of supported research, and past accomplishments, we an achieve our state goal of providing highly qualified MD and PhD scientists for the biomedical research community.